Improved diagnostics for heparin induced thrombocytopenia

Project abstract
Heparin has long been used as an anti-coagulant in the management of coronary artery disease, deep vein
thrombosis, pulmonary embolism, and in the prevention of thrombosis during cardiopulmonary bypass and
extracorporeal membrane oxygenation (ECMO). A small fraction of patients on heparin (0.1% - 5.0%), will
progress to having heparin-induced thrombocytopenia (HIT) which can lead to significant morbidity, particularly
thrombosis, bleeding, and amputation, and in some cases death. The current gold standard assay to detect HIT
is complex, requires C14-serotonin, and can only be performed in several reference laboratories in the US.
Therefore, patients awaiting definitive diagnosis of HIT are on inferior anticoagulants with increased cost and
bleeding risk. Hence there is a need for rapid and accurate detection of HIT. The central hypothesis of this project
is that the mechanical forces generated by platelets provide a physical biomarker of platelet activity and may
serve as a diagnostic marker of HIT. This hypothesis is supported by strong rigor of prior research as well as
strong preliminary data. Platelets mechanically contract with significant force after their initial activation,
contributing to the strength and stability of platelet aggregates as part of normal blood coagulation. Therefore,
our approach is to develop and test a new molecular sensor that can detect the mechanical forces generated by
platelets. To address this need, we have assembled an interdisciplinary team including Dr. Salaita who is a
biophysical chemist, Dr. Roman Sniecinski a recognized expert in perioperative coagulation, and Dr. Cheryl
Maier an expert on immune coagulation disorders including HIT. The team developed a new technology named
MCATS (Mechano-assisted Cas12a Tension Sensor) that can detect the forces generated by human platelets
using a conventional fluorescence plate-reader. Preliminary data shows that MCATS can detect platelet
dysfunction including HIT using 5 uL volume samples of platelets in a 1 hr time window. The MCATS technology
is the center-piece of this proposal and represents the focus of the approach. One goal of this application is to
investigate the signaling link between HIT activation and platelet forces. Another goal is focused on optimizing
the MCATS technology to enhance the signal obtained from human platelets. Finally, we will validate and
benchmark MCATS against that of standard laboratory tests for HIT such as ELISA and SRA, which are the
current standard of care for diagnosing HIT. If successful, then our planned work will lead to the development of
mechanical assays to detect HIT in a rapid and broadly accessible manner.

Public health relevance
Public Health Relevance Heparin is a widely used drug to preventing clotting during surgery. One of the risks of using heparin is a rare but dangerous condition called heparin-induced thrombocytopenia (HIT) which can cause amputations and deaths. Detecting HIT is complex, expensive and time consuming and the planned work is expected to address this problem and improve the management of this disease.